POINTER-zzz: Sleep Ancillary to U.S. Study to Protect Brain Health through Lifestyle Intervention to Reduce Risk of Alzheimer's Disease - Admin

PROJECT SUMMARY To date, greater than 30% of enrolled POINTER-zzz participants are from under-represented racial and ethnic minority groups. A second NIA-funded ancillary study to the parent U.S. POINTER trial, POINTER- Neurovascular (POINTER-NV), presents a unique opportunity to increase the scientific impact of POINTER- zzz by allowing co-examination objective measures of sleep with peripheral and central measures of blood flow in a racially and ethnically diverse group of participants. This Administrative Supplement will allow us to increase co-participation of individuals from under-represented groups in the two ancillary studies to examine links between lifestyle-induced changes in sleep as they relate to lifestyle-induced changes in vascular health. Lifestyle intervention has the potential to improve sleep quality and reduce incident sleep apnea, which has been bi-directionally linked to vascular disease in older adults. One potent health target for the POINTER lifestyle intervention is cardiovascular health, which is disproportionately more prevalent in racial and ethnic minority older adults. Thus, the opportunity to co-enroll additional participants who are at high risk for cardiovascular disease into POINTER-zzz could contribute new important information to inform precision medicine strategies targeting AD risk reduction in older adults at risk for cognitive decline and dementia.

Public health relevance
PROJECT NARRATIVE This Administrative Supplement to the POINTER-zzz, a sleep ancillary study to the U.S. POINTER trial, will allow recruitment of additional participants who are also taking part in another ancillary study focused on neurovascular health (POINTER-NV). The focus of recruitment for the Administrative Supplement will be Black and Hispanic parent trial participants. The overlapping participation in these two ancillary studies will greatly magnify our ability to link outcomes related to sleep and neurovascular health, particularly as they relate to parent trial cognitive outcomes. We know of no intervention studies that have collected objective data on sleep metrics and neurovascular measures of cerebral autoregulation and vasomotor reactivity from a racially and ethnically diverse cohort of participants, in the setting of a lifestyle intervention trial.